BACTERIAL GENOME RESTRICTION DIGESTS BY FLOW CYTOMETRIC DNA FRAGMENT SIZING

DNA fragment size analysis by flow cytometry has been applied to the analysis of restriction enzyme digest of 3 bacterial gnomes E. coli, E. herbicola, and E. erwinia. Distinct restriction fragment fingerprints were observed and served as the basis for discriminating among the three species. Details are contained in a Research Highlight and a publication that is in press in Cytometry.